Causes and Consequences of Leptomeningeal Bleeding in Cerebral Amyloid Angiopathy

Project Summary/Abstract: Cerebral amyloid angiopathy (CAA), a small vessel disease characterized by the
deposition of amyloid-β in the walls of cortical and leptomeningeal blood vessels of the brain, is a leading cause
of intracerebral hemorrhage (ICH) in the elderly. Patients with CAA present clinically with hemorrhagic lesions,
including acute symptomatic lobar ICH, convexal subarachnoid hemorrhage (cSAH), and the chronic
manifestation of cSAH, cortical superficial siderosis (cSS). There are currently no effective treatments for
hemorrhage prevention in CAA, in part due to limitations in our understanding of the mechanisms leading to
vessel rupture and hemorrhage. Recent studies suggest that leptomeningeal bleeding is an important risk factor
in the development of lobar ICH. The proposed research focuses on the central hypothesis that severe
leptomeningeal CAA and leptomeningeal bleeding (including cSAH and cSS) cause CAA-related lobar
ICH. The applicant will use a multimodal approach including ex vivo MRI-targeted neuropathological examination
of human brain tissue and complementary in vivo imaging of mouse models of CAA. Inflammatory-mediated
leptomeningeal vascular remodeling will be explored as a putative cause of leptomeningeal bleeding and
potentially lobar ICH. Additionally, the consequences of leptomeningeal bleeding for the underlying cortex and
cortical vasculature will be investigated. Inflammation secondary to blood products is hypothesized to be a crucial
mechanistic link between initial leptomeningeal bleeding and rupture of additional blood vessels leading to ICH.
This hypothesis will be explored in human brain tissue and in two complementary animal models of cSAH/cSS
developed by the applicant. Importantly, patients with CAA typically present to clinical attention when the
underlying vessel pathology has significantly progressed, and bleeding events have begun to occur. The
overarching goal of these studies is to identify novel, and urgently needed, treatment targets for
hemorrhage prevention, accessible at the time of symptomatic patient presentation.
The proposed experiments and career development plan build on the applicant’s strong background in
in vivo optical imaging of rodent models, with the career development plan focused on expanding the applicant’s
knowledge base in advanced neuropathology and neuroinflammation through experimental training, formal
coursework, conferences, and mentorship. The excellent scientific environment and resources of Massachusetts
General Hospital and Harvard Medical School as well as the applicant’s outstanding mentorship team (including
mentor, co-mentor, and scientific advisory board) of internationally recognized leaders in the fields of CAA,
ICH/SAH, in vivo optical imaging, neuropathology, and neuroinflammation, will be critical to the applicant’s career
development and completion of the proposed work. This K08 award will be instrumental in the applicant’s
progression to a successful independent career as a clinician-scientist focused on ICH.

Public health relevance
Project Narrative Cerebral amyloid angiopathy (CAA) is one of the leading causes of symptomatic intracerebral hemorrhage (ICH) in the elderly, and bleeding from the leptomeningeal vasculature has recently been implicated in the pathophysiological mechanisms underlying CAA-related ICH. The proposed research will use a multimodal approach combining neuropathological analysis of human tissue and in vivo imaging of mouse models to investigate the causes and consequences of leptomeningeal bleeding in CAA. This project has the potential to uncover novel, and much-needed, therapeutic targets for the prevention of CAA-related ICH.